Xylitol and the Prevention of Periodontal disease and Preterm Birth (XaPPP) Trial

Preterm birth (PTB) is the leading cause of under-5-year-old mortality and neurodevelopmental impairment
worldwide and affects between 5-29% of pregnancies. Periodontal disease (PD), including either gingivitis or
periodontitis, is a risk factor for PTB. Unfortunately, PTB and PD disproportionately occur in many low- and
middle-income countries where access to physicians and dentists is limited. Using a novel inexpensive and non-
invasive treatment approach, we recently completed a cluster-randomized trial in Malawi entitled the Prevention
of Prematurity and Xylitol (PPaX) Trial in which we demonstrated that use of xylitol-containing chewing gum
significantly reduced clinical metrics of maternal periodontal disease (p=0.03) and the occurrence of PTB (xylitol
12.6% vs control 16.5%, aRR 0.76, 95% CI 0.59-0.99). Xylitol is a naturally occurring sugar alcohol found in
several chewing gum products and is a prebiotic, known to prevent the growth of periodontopathic bacteria and
dampen the pro-inflammatory cascade. As infection and inflammation are risk factors for PTB, xylitol may be a
novel, inexpensive innovation that improves maternal and offspring outcomes.
While the results of the PPaX trial are promising, we propose to conduct a double-blinded, 3-arm, placebo-
controlled trial to address the PPaX trial’s limitations and prove the results are reproducible. PPaX trial limitations
included: (a) lack of blinding, (b) lack of placebo control, (c) lack of optimized xylitol dosing based on recent
evidence that 5-10 grams of xylitol/day is best for oral health benefit, (d) and lack of individual randomization
(PPaX was cluster randomized with only 8 clusters). These limitations inflate the risk of spurious findings. The
proposed individually randomized trial will enroll n=6000 Malawian pregnant individuals at <20 weeks’ gestation.
The 3 study arms (n=2000 each) will be (a) an optimized dose of xylitol-containing chewing gum (6.4 grams/day),
(b) the PPaX trial xylitol dose (2.1 grams/day), or (c) flavored sorbitol gum base (placebo control). The Specific
Aims of the research are to determine whether optimized-dose xylitol vs placebo or PPaX-trial-dose xylitol vs
placebo impacts: (1) the incidence of PTB or low birthweight offspring (co-primary outcomes), (2) clinical metrics
of PD, and (3) adverse offspring outcomes including neonatal mortality, infant mortality and 12-month
neurodevelopmental outcomes.
We anticipate xylitol-containing chewing gum will prevent PTB and low birthweight offspring and improve overall
maternal and offspring outcomes, with most benefit seen with the optimized xylitol daily dose. The findings from
this work will definitively prove and confirm whether xylitol has such preventive benefit in a Malawian population,
confirm an optimal daily dose, lead to definitive action in Malawi and lay the foundation for a future multi-country,
multi-institution clinical trial confirming generalizable benefit worldwide. This trial has the potential to lead to a
momentous breakthrough in medicine that could ultimately prevent death and/or disability for millions worldwide.

Public health relevance
Project Narrative This R01 proposal aims to perform a definitive, three-arm, placebo-controlled, individually-randomized phase III clinical trial evaluating the use of a simple, affordable, accessible prenatal intervention, xylitol-containing chewing gum, among pregnant individuals in Malawi on preventing (a) preterm birth and low birthweight offspring (co- primary outcomes), (b) periodontal disease (clinical metrics of gingivitis and periodontitis), and (c) offspring adverse outcomes including neonatal mortality, infant mortality, and 12-month neurodevelopmental disability. Building upon prior preliminary work suggesting benefit with xylitol, the results of this trial will definitively demonstrate whether xylitol-containing chewing gum improves maternal and offspring outcomes in Malawi and lay the foundation for future multi-country, multi-institutional trial, including within the United States, to confirm generalizable benefit worldwide.